Family-Based, Culturally-Centered Diabetes Intervention with Ojibwe Communities

Project Summary/Abstract
Type 2 diabetes is a significant health disparity for many American Indian (AI) communities. The goal of this
competitive renewal research is to enhance, implement, and evaluate the effectiveness of a culturally tailored,
intergenerational diabetes management and prevention intervention, “Together on Diabetes.” The program
activates family and cultural practices that encourage healthy diets and physical activities, promote stress-
coping resources and responses, and reconnect families via a home-based intervention taught by AI
paraprofessional Family Health Coaches. The proposed Community Based Participatory Research will enroll
“target” adult caregivers diagnosed with type 2 diabetes and their children, ages 10-16 years, with the goal of
tapping into motivational reciprocity between the two generations. The work builds on an existing research
collaboration with five Ojibwe tribal communities in the Midwest to implement a randomized controlled study (N
= 280 families) with a wait-list design respectful of cultural norms of inclusion. The study will evaluate
effectiveness of the intervention on adult physiological (primary outcome = HbA1c), behavioral, and mental
health and children's psychosocial, familial, behavioral and physiological risk and protective factors for
diabetes. The research will also identify stress-coping mechanisms that mediate the impact of the intervention
on health. A novel collaborative, qualitative evaluation technique will map potential “ripple effects” of the
intervention within families and communities. If effective, the intervention will promote dissemination and
scaling with tribal health coaches, community involvement, and stakeholder (health providers, health and
human service agencies) input.

Public health relevance
Project Narrative The goal of this research is to evaluate the impact of a culturally tailored, intergenerational, home-based type 2 diabetes intervention for American Indian adult diabetes-related health outcomes including HbA1c. We will also evaluate the impact of the program on enrolled adult's children in terms of diabetes risk and protective factors. If the intervention is effective, American Indian communities may benefit from an empirically supported, family-based model with promise to break the cycles of intergenerational diabetes.